Effectiveness and predictors of response for a technology-based reading intervention in the home

Project Summary/Abstract.
Reading Disability (RD) is the most common learning disability, affecting 10 – 15% of school age children. It
incurs major functional impairments at all stages of life, with a wealth of data documenting lifelong disadvantages
in educational and occupational attainment. Therefore, identifying effective and affordable treatments for RD is
a high priority for reading researchers, clinicians and educators. Problematically, current evidence-based reading
interventions largely rely on services by trained specialists, either in well-resourced classrooms or clinical
settings. As such, under-resourced schools (or countries) often are unable to provide reading interventions for
their students. In recent years, technology-based reading interventions have been proposed as a means of
overcoming these challenges, as they can be administered in the home, without direct expert supervision -
thereby minimizing resource demands. In the area of reading-focused EdTech, GraphoLearn has emerged as a
leader, with the largest evidence-base to date. However, the vast majority of studies to date have been conducted
in highly controlled settings, rather than the home environment it was intended for – leaving open questions
about effectiveness. Additionally, similar to any intervention, not all children with RD benefit equally from
treatment; however little attention has been given to identifying predictors of treatment response.
Here we propose to evaluate the effectiveness of home-administered GraphoLearn through the implementation
of a large-scale, randomized controlled trial (RCT) in 450 reading disabled children (boys and girls, ages 6.0-
10.0). To accomplish this goal rapidly and with minimal cost, we will recruit participants from the Healthy Brain
Network [HBN], an ongoing study of mental health and learning disorders in children, ages 5.0-21.0, whose
family have concerns about behavior and/or learning (target n = 10,000; current n = 3000+). The availability of
comprehensive characterizations (e.g., demographic, cognitive, mental health, EEG, multimodal MRI) for all HBN
participants makes the sample optimal for exploring an extensive set of participant and environmental factors
that may affect treatment outcomes (i.e., demographic, cognitive, emotional, neurobiological, environmental).
Specific aims of the proposed work are to: 1) Evaluate the effectiveness of GraphoLearn in a large sample of
children with RD, and 2) Identify participant-related and environment-level factors that are significantly
associated with GraphoLearn outcomes. To accomplish this latter aim, sophisticated machine learning
approaches (Random Forest Regression models) will be employed.

Public health relevance
Project Narrative This project is motivated by two significant overarching problems (1) existing avenues for reading intervention in the US are not available to most children in need of help, and (2) across children there is substantial variability in pre-to-post intervention gains in reading. This project will evaluate the effectiveness of a home delivered technology-based (Edtech) reading intervention in a large and diverse sample of children, and identify factors that facilitate (or hinder) positive Edtech intervention outcomes.